Engineering Modular Protein Inhibitors for Selective Targeting of Pathological Biomolecules

PROJECT SUMMARY/ABSTRACT
Multifunctional proteins are excellent candidates for developing novel therapeutics, however, natural proteins
have a limited span for binding affinity, selectivity for a specific target, or propensity to control binding to proteins
other than their intended therapeutic target. My research lab aims to enhance the protein engineering and design
toolbox by exploring the relationships between protein sequence, structure, and function in multifunctional
proteins. We aim to engineer designer protein scaffolds that can bind selectively to one or more specific targets,
minimizing off-target effects. Multifunctional metalloproteinases (MPs) and their natural inhibitors, tissue
inhibitors of metalloproteinases (TIMPs), interact with each other and other cell signaling molecules in a complex
network to orchestrate key cellular functions, including remodeling of the extracellular matrix (ECM). TIMPs have
unique features that make them ideal scaffolds for protein engineering and design, including five flexible loops
that provide a vast protein-protein interacting interface for improving or switching multifunctional proteins. TIMPs
share structure and function similarities with a single chain fragment of monoclonal antibody (scFv mAb) in
binding to the target. mAbs are well-established protein therapeutics with numerous FDA-approved examples,
however, mAbs are not natural inhibitors of enzymes and many other ECM targets. We aim to harness the full
potential of mAbs and the multifunctional capability of TIMPs by generating engineered hybrid mAb-TIMP protein
scaffolds using a combination of experimental and computational approaches. To reach this goal, we need to
overcome the limitations of directed evolution for protein engineering and design multifunctional enzyme
inhibitors with high selective binding to specific targets using computational approaches like machine learning.
This MIRA grant will address these limitations through a five-year strategy composed of two primary research
strategies. In research strategy 1, we aim to develop new protein engineering and design platforms for
engineering multifunctional enzyme inhibitors by modifying yeast surface display and high throughput screening
methods. Using machine learning, we will generate a feedback loop between cycles of directed evolution and
rational protein design that will allow us to engineer and design novel TIMP variants with absolute selectivity for
specific MPs or other cell signaling proteins. In research strategy 2, we aim to understand the molecular
mechanism of engineered proteins --- those driving selective binding to MPs and cell receptors, and growth
factors using protein structural studies. Further, we will understand the effect of these modular multifunctional
protein inhibitors in cell-based assays. The scope of this work is beyond the interaction of mAbs or TIMPs with
target proteins in ECM—the strategies and tools developed here can be used to engineer and design any
multifunctional protein, enzyme, or inhibitor to regulate complex biological systems and develop new and
improved protein therapeutics with higher selectivity for multiple pathological protein targets with low side effects.

Public health relevance
PROJECT NARRATIVE Multifunctional proteins, such as enzyme inhibitors, play a key role in complex biological systems such as extracellular matrix and are excellent protein scaffolds for developing novel diagnostic and therapeutic tools, especially for diseases that do not respond to conventional treatments. The overarching goal of my research group is to combine protein engineering and design techniques, such as directed evolution and rational design, with computational methods like machine learning, to develop a new class of modular protein-based inhibitors that selectively inhibit specific protein targets within the extracellular matrix responsible for diseases. The protein engineering strategies and tools developed in this research will shed light on developing novel protein-based therapeutics that regulate complex biological systems while unraveling the protein sequence-structure-function relationship of selective multifunctional protein inhibitors with low off-target effects.